Mentoring Patient-Oriented Research on Advances to Optimize Engagement in HIV Care

Project Abstract
Dr. Christopoulos is an infectious disease physician and Associate Professor of Medicine in the Division of
HIV, ID, and Global Medicine at UCSF. Her research over the past ten years has focused on improving
engagement in HIV care for underserved urban populations by identifying those at risk for poor engagement,
understanding barriers to and facilitators of engagement, and developing interventions to support engagement.
She has mentored numerous early career investigators, including pre-doctoral students, post-doctoral fellows,
and junior faculty but now seeks the protected time of the K24 award to increase the depth and scope of her
mentorship, undertake dedicated mentorship skills training, and grow her program of patient oriented research.
The COVID-19 pandemic has highlighted further the need for rigorous evaluation of the impact of innovations
in HIV care delivery to ensure their use does not widen HIV health disparities. In this application, Dr.
Christopoulos proposes a comprehensive mentoring, research, and career development plan to promote the
equitable delivery of HIV care and treatment in a post-COVID landscape. Leveraging the infrastructure of the
CFAR Network of Integrated Clinical Systems (CNICS) and her role as UCSF site PI, the research proposed in
this application seeks to investigate the impact of advances in HIV care and treatment, i.e., telehealth, long-
acting injectable antiretroviral therapy, on retention and viral suppression. In addition to the resources of
CNICS, which include a mentoring core, Dr. Christopoulos will utilize an implementation science R01 on long-
acting injectable antiretroviral therapy, training and career resources at UCSF, and a robust network of
multidisciplinary collaborators to provide mentees with training opportunities, preliminary data, and platforms
on which to build new research. Through the guidance of an experienced senior mentoring team, formal
didactics, and mentee feedback, she will augment and formalize her mentoring abilities and approach with
additional training in mentoring across differences and supporting under-represented minority (URM)
investigators, building an equity focus in her mentoring as well as her research. The K24 is instrumental to
achieving her long-term career goals of becoming an international leader on the topic of engagement in HIV
care and maximizing the impact of her scientific pursuits by training the next generation of researchers focused
on optimizing HIV care engagement.

Public health relevance
Project Narrative The post-COVID landscape holds several advances in HIV care and treatment, chief among them the advent of telehealth and the FDA-approval of long-acting injectable antiretroviral therapy. It is critical to understand the impact of these innovations on retention in care and viral suppression and ensure that their use does not widen existing disparities. This K24 award will support Dr. Christopoulos in having protected time to mentor the next generation of researchers focused on improving engagement in care for persons living with HIV.